Determining Mechanisms of Cerebral Blood Flow and Metabolism Derangements in Pediatric Cerebral Malaria (FLOW)

Project Summary
Cerebral malaria (CM), even with effective anti-malarial drugs, results in >450,000 deaths annually, with
pediatric case fatality rates ranging from 15-30%. This equates to >1300 dead children on any given day.
Long-term neurologic sequelae are identified in 30-50% of survivors. The neuropathogenesis of CM is
unclear and under-investigated, but an improved understanding is necessary to develop efficacious
therapies that improve outcomes. We have, in two different populations of African children with CM,
identified five distinct patterns of abnormal Transcranial Doppler Ultrasound (TCD) cerebral blood flow
velocities and waveforms, each with differing risks of neurologic morbidity or mortality. In a small cohort
of children with CM, we have also determined that multiple different types of disrupted flow-
metabolism coupling and cerebral metabolic dysfunction (luxury perfusion, misery perfusion, ischemia,
mitochondrial dysfunction) occurred in 85% of patients with CM. We hypothesize that in children with
CM, due to parasite and/or host factors, altered bioavailability of various vasoactive peptides results in
altered cerebrovascular tone/cerebral blood flow, flow metabolism uncoupling, and cerebral metabolic
dysfunction, with different combinations of abnormalities inherently associated with differing kinds and
risk of neurologic injury. This project will establish altered cerebral blood flow (CBF) and metabolism as
mechanistic contributors to neurologic injury in CM for the first time. Using non-targeted metabolomics,
we will also determine putative peptides contributing to the different categories of abnormal CBF and
metabolism. These peptides may then act as biomarkers of underlying mechanisms of injury or as
therapeutic targets. Using the large amounts of data that will be captured in the proposed work,
machine learning/cluster analysis will, also for the first time, determine endotypes of CM. This work is
innovative in that we will establish new mechanisms of neurologic injury in CM, identify associated
vasoactive peptides, and develop a novel framework that is a necessary step towards the delivery of
precision medicine in CM. Additionally, the work is innovative in that we will further develop and
validate a portable, non-invasive approach to measure CBF, cerebral metabolic rate of oxygen
consumption, and oxygen extraction fraction, an approach that may have widespread implications for
patient neuromonitoring during any acute neurocritical illness across all settings.

Public health relevance
Project Narrative Brain injury due to cerebral malaria (CM) contributes significantly to childhood death and disability in sub-Saharan Africa, but multiple therapeutic trails have failed to demonstrate approaches that improve outcomes. Our recent work has highlighted that, in addition to commonly accepted mechanisms of neurologic injury, abnormal cerebral blood flow and dysregulated metabolism are ubiquitous. This project aims to establish these as novel mechanisms of neurologic injury, identify putative metabolites, and develop clinically relevant endotypes that encompass the heterogeneity of this disease, necessary steps that lead to the utilization of targeted, mechanistic specific adjunctive therapeutic approaches.